The RCMI Program in Health Disparities at Meharry Medical College - Supplement

PROJECT SUMMARY
Substance use disorders (SUDs) are a major public health issue that has recently more than doubled in
prevalence among Americans in the last few years, from affecting 20 million in 2018 to 46.3 million Americans
in 2021. Those affected by SUD disproportionately experience negative social determinants of health (SDoH),
including inadequate access to safe housing, transportation, education, employment opportunities, and nutritious
foods. These SDoH are connected with low self-esteem, self-efficacy, and failed attempts at SUD abstinence.
Collecting and integrating SDoH information as part of patients’ electronic health records (EHR) for clinical
modeling could help uncover patient experiences and behaviors related to SUD, but the majority of SDoH are
embedded in unstructured free text. Additionally, the SUD diagnosis is under represented in structural EHR.
Therefore, an automated and more accurate approach is needed to extract SDoH and identify SUDs. Natural
language processing (NLP) can unlock the information conveyed in clinical narratives, thus playing a critical role
in real-world studies. Methods and tools are being developed to facilitate such extractions; however, these tools
are still under study for cohort-specific samples and unstructured text analytics is complex. To advance health
disparity studies and improve understanding of patient characteristics of the SUD patients from the underserved
population at Meharry, it is a high priority to explore machine learning tools to extract SDoH factors and identify
SUDs diagnosis. In this proposal, we will address the challenge of SDoH extraction and SUDs identification
from unstructured clinical notes or patient surveys to generate a consistent framework that can aid in
identifying, understanding, treating, and predicting SUDs and associated outcomes (e.g. relapse). We
will solve this challenge by developing two NLP pipelines, one for SDoH extraction and one for SUDs
identification. We will focus on SUD patients with cocaine, cannabis, and opioid use disorders. The SDoH NLP
pipeline will mine and enrich data in five SDoH domains defined by CDC including economic stability, education,
health care access, neighborhood environment, and social and community context. Name entity recognition
methods will be investigated in the SUDs NLP pipeline. We will develop and test the two pipelines in a cohort of
200-500 patients and compare our pipeline-derived results to manual review outcome to measure the NLP model
performance. We hypothesize that a high performance SDoH NLP pipeline will be developed that will fit to our
application, and more SUD patients will be identified. The ultimate goal of our studies is to identify patients at
risk of SUDs, identify risk factors associated with health outcomes, and improve patient health outcome
prediction that will potentially help clinical decision support and healthcare management. In order to accomplish
this, we will integrate the SDoH associated factors and SUD diagnosis that we obtained from the two NLP
pipelines, along with other phenotype risk factors being extracted from EHR structured data. We hypothesize
that the performance of the SUD predictive model will be increased after SDoH are included.

Public health relevance
PROJECT NARRATIVE Social determinants of health (SDoH) are connected with low self-esteem, self-efficacy, and failed attempts at substance use disorder (SUD) abstinence. Collecting and integrating SDoH information as part of patients’ electronic health records (EHR) for clinical modeling could help uncover health disparities, patient experiences and behaviors related to SUD. In this proposal, we will to address the challenge of SDoH extraction and SUDs identification from unstructured clinical notes or patient surveys by developing two natural language processing (NLP) pipelines, and build SUD prediction models integrating the SDoH associated factors and SUD diagnosis that will be obtained from the two NLP pipelines, along with other phenotype risk factors being extracted from EHR structured data.